Interdisciplinary Training in Musculoskeletal Research

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
This application describes a new Training Program at the University of Colorado (CU) entitled “Interdisciplinary Training in Musculoskeletal Research”. The overarching mission of this new Program is to provide comprehensive interdisciplinary training in musculoskeletal science with the aim of developing the next generation of outstanding musculoskeletal investigators. The Program will be administratively anchored in the Colorado Program for Musculoskeletal Research (CPMR) and the Department of Orthopedics on the Anschutz Medical Campus. It includes 32 senior and junior preceptors from 18 basic science and clinical departments across all 4 CU campuses - Anschutz, Boulder, Denver, and Colorado Springs. Preceptors and their labs are coordinated in the Program to provide research, didactic education and mentoring to 4 predoctoral and 2 postdoctoral trainees in conjunction with a broader cross section of unseated trainees pursuing advanced education within the CPMR. To accomplish this mission, we have assembled a Program that evaluates and recruits top talent from trainee pools and provides a series of formalized education components that are conjoined with top-notch research training with world class preceptors. Beyond laboratory research, formal programming includes a five-lecture series Musculoskeletal Science Curriculum, the Mack Clayton Seminars (preeminent visiting scientists), Work-in-Progress Meetings and Journal Clubs, the Annual CPMR Symposium and D’Ambrosia Lectureship, a weekly Specific Aims Development Meeting, and preferential and subsidized access to Research Core Services for trainees and their preceptors. University-level education opportunities constructed and supported by the Colorado Clinical and Translational Sciences Institute are layered in, including training in mentoring, biostatistics, and research management. Program activities will be developed, implemented, executed, and supervised by a hierarchy of oversight Committees that collaborate with Program leadership to administer all aspects of activity. These Committees include Trainee Selection and Progress, Curriculum, Clayton Seminars, Annual Symposium and Trainee Feedback. The Program Directors will coordinate in real time with these Committees for overall Program management, collectively reporting to an Internal and an External advisory board and an Executive Committee to facilitate overall Program oversight, evaluation, problem solving, and vision setting. Overall, the training enabled through this new Program, which includes a focus on mentoring trainees towards independent funding, will be a springboard to development of the next generation of collaborative and innovative musculoskeletal investigators aiming to translate basic discoveries into novel human therapies.

Public health relevance
Narrative This application herein describes a new T32 Training Program at the University of Colorado entitled “Interdisciplinary Training in Musculoskeletal Research” requesting support for 4 predoctoral and 2 postdoctoral trainees. The overarching mission of the Program is to provide comprehensive interdisciplinary training in musculoskeletal science with the aim of developing the next generation of outstanding musculoskeletal investigators.